Molecular mechanisms of CCM signaling

DESCRIPTION (provided by applicant): Cerebral cavernous malformations (CCMs) are relatively common vascular malformations that cause stroke and seizure in mid-life. Human genetic studies have identified 3 CCM disease genes that encode intracellular adaptors, KRIT1 (CCM1), CCM2, and PDCD10 (CCM3). Genetic studies in fish and mice and biochemical studies have demonstrated that CCM proteins interact with each other and with the endothelial receptor HEG during cardiovascular development. Human CCMs exhibit defective endothelial junctions and the CCM pathway is required in endothelial cells during cardiovascular development, but the downstream signals by which CCM proteins regulate cardiovascular function are not known. Our preliminary studies have identified two new downstream arms of the CCM pathway. First, we find that CCM3 coupling to the GCK-III family of Sterile 20-like serine/threonine kinases (STKs) that includes MST4, STK24 and STK25 is required for cardiovascular development in vivo and regulates RHO activity in endothelial cells in vitro. Second, we have identified a novel, endothelial- specific CCM2 homologue, CCM2L, that binds CCM1 and HEG but does not bind CCM3. Preliminary studies reveal that CCM2L is a strong activator of MEKK3, an endothelial MAPK required for mouse cardiovascular development. CCM2L-deficient mice exhibit strong genetic interaction with HEG, demonstrating participation by this novel protein in the CCM signaling pathway. We propose that CCM signaling regulates endothelial cell function through two distinct downstream pathways, a CCM3-STK pathway required for cell junctions and a CCM2L-MEKK3 pathway that regulates transcription. Defining the molecular components and functional roles of these novel downstream pathways will reveal how CCM signaling participates in cardiovascular development and human vascular disease.

Public health relevance
PUBLIC HEALTH RELEVANCE: Cerebral cavernous malformations (CCMs) are relatively common vascular malformations that cause stroke and seizure in mid-life. Defining the molecular components and functional roles of these novel downstream pathways will reveal how CCM signaling participates in cardiovascular development and human vascular disease. Cerebral cavernous malformations (CCMs) are relatively common vascular malformations that cause stroke and seizure in mid-life. Defining the molecular components and functional roles of these novel downstream pathways will reveal how CCM signaling participates in cardiovascular development and human vascular disease. __SpecificAimsTextDelimiter__ Specific Aims Cerebral cavernous malformations (CCMs) are common vascular malformations that cause stroke and seizure in mid-life. Human genetic studies have identified 3 CCM disease genes that encode intracellular adaptors, KRIT1 (CCM1), CCM2, and PDCD10 (CCM3). Genetic studies in fish and mice and biochemical studies have demonstrated that CCM proteins interact with each other and with the endothelial receptor HEG in a signaling complex required in endothelial cells during cardiovascular development. How CCM signaling regulates cardiovascular development and how its loss results in human vascular disease are unknown because the downstream signals by which this pathway regulates endothelial cell function have not been identified. This proposal will investigate two downstream arms of the CCM pathway that have recently been identified in our laboratory. We have identified the GCK-III family of Sterile 20-like serine/threonine kinases (STKs) as downstream effectors of CCM3 that are required for cardiovascular development in vivo and that link the pathway to RHO, a known regulator of cell junctions. We have also identified a novel CCM2 homologue, CCM2L, that is expressed selectively in endothelial cells. Preliminary biochemical studies reveal that CCM2L binds CCM1 and HEG and is a strong activator of MEKK3, but does not couple to CCM3. Genetic studies using recently generated CCM2L-deficient mice confirm CCM2L participation in the known CCM signaling pathway. We propose that CCM signaling regulates endothelial cell function through two distinct downstream pathways, a CCM3-STK pathway that controls cell junctions and a CCM2L-MEKK3 pathway that regulates transcription. Defining the molecular components and functional roles of these novel downstream pathways will reveal how CCM signaling participates in cardiovascular development and human vascular disease. Aim 1. To determine if CCM signaling regulates endothelial junctions through a CCM3-STK-RHO pathway. We find that loss of HEG or CCM2 in both mice and fish confers defective endothelial junctions like those seen in human CCMs, suggesting that CCM regulation of endothelial junctions is central to its role in cardiovascular development and human vascular disease. Consistent with these in vivo findings, endothelial loss of CCM signaling in vitro results in increased RHO activity and defective endothelial junctions, but how CCM signaling regulates RHO and endothelial junctions is not known. Our preliminary studies indicate that the STKs MST4, STK24 and STK25 lie downstream of CCM3 in zebrafish embryos and that these STKs regulate endothelial junctions and RHO in vitro. Genetic studies in Drosophila have identified the closely related STK slik as having an analogous role in regulating Rho and epithelial cell junctions through the moesin protein, and MST4 has recently been shown to directly regulate the activity of the moesin-like protein ezrin in intestinal epithelial cells. We hypothesize that CCM signaling controls endothelial cell junctions through a conserved mechanism in which STKs regulate Rho through moesin-like proteins. We will test this hypothesis using (i) biochemical studies to determine if CCM signaling and STKs controls the activity of moesin-like proteins and RHO, (ii) in vitro studies of endothelial cells to test the role of CCM3, STKs, moesin and RHO on cell junctions, and (iii) genetic and pharmacologic studies to further investigate CCM3-STK signaling in zebrafish embryos. The goal of these studies is to define the molecular pathway from CCM proteins to endothelial junctions. Aim 2. To determine if CCM signaling regulates MEKK3 and endothelial gene expression via a novel CCM2 homologue, CCM2L. We have identified a novel CCM2 homologue, CCM2L, that is selectively expressed in endothelial cells in vivo. Like CCM2, CCM2L interacts biochemically with HEG and CCM1 but, in contrast to CCM2, CCM2L does not bind CCM3. CCM2 has been reported to bind MEKK3, a MAPK required in endothelial cells during development that activates the transcription factor MEF2C, but the role of MEKK3 in the CCM signaling pathway is undefined. We find that CCM2L binds MEKK3 more strongly than CCM2 and that CCM2L is a potent activator of MEKK3. To address the in vivo role of CCM2L and compare it to CCM2 we have generated Ccm2LGFP and Ccm2fl mice that express GFP in place of the Ccm2L gene and permit conditional deletion of the Ccm2 gene. Preliminary studies reveal that CCM2L-deficient animals are liveborn but that animals lacking both CCM2L and HEG die by E12, confirming the role of this novel protein in the known CCM signaling pathway. We hypothesize that CCM2L-MEKK3 signaling regulates endothelial transcription through a pathway distinct from CCM2-CCM3 regulation of cell junctions. We will test this hypothesis using (i) biochemical studies to define the CCM2L and CCM2 signaling complexes in endothelial cells, (ii) in vitro studies to determine if CCM signaling regulates MEKK3 and MEF2 through CCM2L in endothelial cells, and (iii) genetic studies in mice to define the role of CCM2L and CCM-MEKK3 signaling in vivo. We predict that these studies will define a novel arm of the CCM signaling pathway that regulates endothelial transcription and yield new insight into CCM disease pathogenesis.